Plasticity of auditory electrical synapses

Abstract
Electrical synapses, mediated by neuronal gap junctions (GJs), are widespread throughout the auditory pathway.
However, the functional roles and properties of electrical synapses in the auditory system remain poorly
understood. Our proposal aims to contribute to a better understanding of the properties of electrical synaptic
transmission in the auditory system by investigating the molecular mechanisms responsible for plastic changes
of electrical transmission at ‘mixed’, electrical and chemical, synaptic contacts that couple primary auditory
afferents to the Mauthner (M-) cells in fish. Facilitated by their unique experimental accessibility, our previous
investigations revealed that electrical (and chemical) transmission at these mixed synapses undergo activity-
dependent synaptic potentiation. There is a prevailing perception that modifications of electrical transmission
only result from direct modification of the properties of already existing GJ channels. This interpretation results
from the narrow belief that electrical synapses represent simple clusters of intercellular channels. However,
rather than fixed, GJs are quite dynamic structures at which channels turn over to maintain their strength at rates
comparable to those of glutamate receptors in chemical synapses. Accordingly, our progress indicates that
regulated insertion and removal of GJ channels governed by a molecular scaffold critically contributes to regulate
electrical synapses. We found that the function of ZO-1, a postsynaptic scaffolding protein, is required for the
presence of connexins (the channel-forming proteins). This finding represents a paradigm shift in the
understanding of the molecular mechanisms underlying electrical transmission by demonstrating the hierarchy
of associated intracellular scaffolding proteins over channel-forming proteins. Furthermore, while electrical
transmission is generally thought to occur from single canonical oval-shaped GJ plaques, our preliminary results
show that an electrical synapse operates with multiple GJs requiring the functional association with additional
structures, such as nearby adherens junctions. By taking advantage of the experimental accessibility provided
by these auditory mixed synapses and the zebrafish (ZF) model, we propose to expand the molecular,
organizational, and functional framework of the electrical synapse, to encompass the complexity required to
support plastic changes of function. Our approach provides a powerful window for the analysis of electrical
transmission at which detailed molecular mechanisms will be investigated by combining in-vivo imaging of
transgenic fish at which GJ proteins are tagged with fluorescent proteins, electrophysiology and detailed
anatomical analysis using expansion microscopy with powerful genetic manipulations. Aim 1, is to determine the
role of ZO-1 in mediating plasticity of electrical transmission. Aim 2, is to investigate the functional contribution
of additional scaffold components to plastic changes of electrical transmission. Aim 3, is to expose the
components and anatomical organization of an electrical synapse. In particular, the aim will explore the
anatomical and functional relationship between GJs and adherens junctions, which evidence suggests promotes
the insertion of new GJ channels, therefore suggesting a potential role in synaptic transmission and its plasticity.
The description of novel molecular mechanisms involved in their regulation will contribute to a better
understanding of the dynamics of circuits relevant to auditory dysfunction and the potential identification of novel
therapeutic targets.

Public health relevance
Narrative Electrical synapses, mediated by neuronal gap junctions, are widespread throughout the auditory pathway. However, the functional roles and properties of electrical synapses in the auditory system remain poorly understood. Changes in the strength of electrical synapses are known to dynamically reconfigure neuronal circuits in various neural structures but in contrast to chemical synapses, little is known about the molecular mechanisms that underlie changes in the strength of electrical synapses. The proposed research will lead to the identification of novel molecular mechanisms involved in the regulation of electrical synapses that could fundamentally change the way we understand the organization of circuits associated with auditory dysfunction, thus contributing to the identification of novel therapeutic targets.